ROLE OF THE POLO BOX FOR MITOTIC FUNCTIONS OF MAMMALIAN POLO KINASE

Members of the polo subfamily of protein kinases play pivotal roles in cell proliferation. In addition to the kinase domain, polo kinases have a strikingly conserved sequence in the non-catalytic domain, termed the polo-box. The function of the polo-box is currently undefined. The mammalian polo-like kinase, Plk, is a functional homologue of Saccharomyces cerevisiae Cdc5. Here we show that Plk localizes at the spindle poles and cytokinetic neck filaments. Without impairing kinase activity, a conservative mutation in the polo-box disrupts the capacity of Plk to complement the defect associated with a cdc5-1 temperature-sensitive mutation, and to localize to these subcellular structures. Our data provide evidence that the polo-box plays a critical role in Plk function, likely by directing its subcellular localization.